Viral Biosensors of Host Post-Translational Modifications

PROJECT SUMMARY
Viruses and their hosts are engaged in a constant, dynamic struggle as part of an ongoing evolutionary arms
race. It is well established that viruses continually evolve new offensive strategies, like the production of proteins
that disrupt host defenses, while hosts develop countermeasures to detect and neutralize viruses. However, a
key question that remains is: how do viruses perceive and respond to host cues in real-time? This ability to sense
and adapt to the intracellular environment, akin to real-time "decision-making," which helps them decide when
to replicate, assemble, or escape, plays a crucial role in their fitness and ability to spread. To understand how
viruses sense and respond to their environment, we will study host-derived post-translational modifications
(PTMs) of viral proteins. The overarching hypothesis of this proposal is that viral proteins have evolved as
substrates for host enzyme-derived PTMs to equip them with molecular sensors to coordinate viral life cycle
transitions. Furthermore, we will study how PTMs enable multifunctionality in viral proteins by creating distinct
proteoforms. By understanding the molecular mechanisms of viral biosensors, we expect to pinpoint critical viral
dependencies, revealing promising targets for antiviral intervention.
PTMs, imposed by the host cell, can dramatically alter the functions of viral proteins, influencing their
behavior and ultimately the fate of the virus. Our preliminary mass spectrometry phosphoproteomics analysis of
alphavirus infection revealed phosphorylation sites at the capsid-glycoprotein interface, likely regulated by
plasma membrane-localized kinases, suggesting a functional switch in glycoproteins at the membrane. We
similarly identified phosphorylation sites on herpesvirus latency proteins, which we believe may play a role in
allowing the viral genome to replicate alongside the host genome during latency. Lastly, we discovered
phosphorylation of a SARS-CoV-2 accessory protein by innate immune kinases, suggesting a feedback
mechanism that may modify viral protein function in response to immune activation. Our data have led us to
three specific areas of inquiry, each forming a distinct research project being conducted by PhD students, a
project scientist, and undergraduate trainees:
(1) How do viruses navigate through distinct host subcellular locations during their life cycle?
(2) How do viruses coordinate their life cycle with the host cell cycle?
(3) How do viruses sense, respond to, and exploit the host innate immune system?
The projects and questions outlined in this proposal will serve as the foundation for the primary research in my
laboratory over the next five years. Our questions seek to establish a new research area centered on the
biochemical mechanisms through which viruses act as biosensors of the host signaling environment, how these
biosensors adjust their functionality in response to PTMs, and how targeting these sensors may result in
innovative antiviral therapies.

Public health relevance
PROJECT NARRATIVE This research promises to increase our understanding into how viruses sense, respond, and adapt to their hosts through host-derived post-translational modifications, diversifying viral proteoforms and generating multifunctionality. The relevance of the proposed research to public health lies in its ability to reveal fundamental insights into the virus-host signaling exchange as well as key determinants of proteoform development and protein multifunctionality, which has relevance to developing new treatment strategies for viral infections as well other diseases driven by specific proteoforms. This pertains to NIH’s mission to develop fundamental knowledge that will help understand and treat disease.